Genetic Basis of Lifespan and Healthspan Extension by ACE Inhibition in Drosophila

PROJECT SUMMARY
Studies across a broad range of species have established a common set of evolutionarily conserved hallmarks
of aging, including age-related decline in mobility and mitochondrial failure. This evidence points to the
potential for pharmacological intervention to improve healthy aging and extend longevity. Pharmacological
blockade of the Renin Angiotensin System (RAS) by inhibition of the angiotensin-converting enzyme (ACE) is
an effective therapy in improving age-related impairment of physical function and is a potential strategy to slow
human aging. The beneficial effect of ACE ihibition in reducing age-associated damage of tissues, such as the
skeletal muscle, may be attributed in part by the drug’s capacity to preserve mitochondrial function. However,
improvement in physical performance in response to RAS blockade varies widely in human studies, potentially
due to genetic variation among individuals. Research in this area has been slowed by lack of understanding of
the biology that connects aging, genetics, and response to drug treatment and because of the shortage of
appropriate animal models for biological and intervention studies. To tackle this issue, we propose to leverage
the evolutionary conservation of ACE across species to determine the genetic basis for the anti-aging effect of
the ACEi Lisinopril in the invertebrate model D. melanogaster. The proposed research builds on a powerful
genomics resource, the Drosophila Genetic Reference Panel (DGRP), which consists of genetically distinct
lines of flies derived from a natural population. Our preliminary studies using three genetically diverse DGRP
lines revealed that treatment with Lisinopril extends lifespan and improves age-specific walking in D.
melanogaster, but it does so in a genotype-specific manner. Our data also suggest that genotype-specific
responses to Lisinopril may act, in part, through variation in the degree to which mitochondrial function is
affected by the drug treatment. To address this hypothesis, we propose to use genome-wide association
mapping in 400 new DGRP lines to first identify variants, genes and genetic pathways that respond to ACEi to
ameliorate age-related decline in locomotor activity and extend lifespan (Aim 1). Functional genetic studies
using RNA interference (RNAi) of candidate genes are then proposed to validate the effects of ACEi on
lifespan and healthspan and to test whether these effects are mediated via changes in mitochondrial function
in skeletal muscle (Aim 2). Finally, we propose to evaluate the genome wide effects of ACEi on gene
expression and the metabolome for genes for which RNAi in thoracic muscle extends lifespan and/or
healthspan in order to gain insight into the mechanism(s) by which ACEi modulates lifespan and healthspan
(Aim 3). Completion of the proposed studies will identify genetic and metabolic pathways that regulate the
ACEi-mediated improvement in physical performance in older individuals.

Public health relevance
HEALTH RELEVANCE The world’s population is rapidly growing older, with a concomitant decrease in physical function of older individuals. Pharmacological inhibition of the angiotensin-converting enzyme (ACE) is an effective therapy in improving age-related impairment of physical function and is a potential strategy to slow human aging, but there is variation in improvement of physical performance following ACE inhibition that is likely due to genetic variation. This research will identify novel genes, pathways, and mechanisms that contribute to the beneficial effects of angiotensin- converting enzyme inhibitor therapy on age-related decline in physical mobility, one of the most debilitating effects of aging.